Mentoring translational researchers in perinatal infectious diseases

PROJECT SUMMARY/ABSTRACT
There has been increasing interest in translational research in perinatal infectious diseases among applicants
to medical schools, residency programs, and collaborating subspecialty fellowships (e.g. maternal-fetal
medicine, infectious disease, neonatology) recent years. However, the career development pathways for
translating this interest into successful academic careers remain poorly defined, with relatively few successful
mentors available in academia. The candidate for this K24 Award is an Associate Professor of Maternal-Fetal
Medicine who has established a funded research program to investigate the maternal-fetal immune responses
against infection in pregnancy, including SARS-CoV-2 and malaria. This research program is based upon
strong collaborative relationships with pediatric and adult infectious disease researchers, basic and
translational immunologists, and placental biologists. The PI and her collaborators have forged an effective
multidisciplinary team and have built substantial research infrastructure to develop longitudinal cohorts of
mother/infant dyads from pregnancy, into childhood, and even into the subsequent pregnancy. The recent
epidemics of novel Zika virus and SARS-CoV-2 have demonstrated a clear need to understand the
complexities of maternal-fetal immune interactions, and the potential for maternal exposures to bridge neonatal
and infant immunity. Our current understanding of human maternal-fetal immunity is very limited, and
translational studies are comprised largely of descriptive studies of maternal-fetal antibody transfer. The role of
the placenta in mediating immune cross-talk between mother and fetus, as well as the impact of in utero
exposures on infant immune development need further study. The proposed study will use samples
prospectively collected from well-characterized pregnancy cohorts to identify placental mediators of maternal-
fetal immune interactions in response to SARS-CoV-2. In addition, this award support exploration into a new
area of investigation – the interactions between environmental exposures and susceptibility to infection—which
will spawn new projects for mentees. The primary goal of this K24 will be to develop a cohort of young
investigators with the skills required to conduct high quality translational research in the field of perinatal
infectious diseases. Secondary goals are to encourage their passion for patient-oriented reproductive
infectious diseases research and to help them to become successful independent investigators. Trainees will
include physician scientists at all levels – maternal-fetal medicine, infectious disease, and neonatology fellows,
post-doctoral scholars, residents, and students.

Public health relevance
NARRATIVE Despite increasing interest in translational research in perinatal infectious diseases among applicants to medical schools, residency programs, and collaborating subspecialty fellowships (e.g. maternal-fetal medicine, infectious disease, neonatology), there are relatively few successful physician-scientist mentors in perinatology. The candidate for this K24 Award is an Associate Professor of Maternal-Fetal Medicine who has established a funded research program to investigate the maternal-fetal immune responses against infection in pregnancy, including SARS-CoV-2 and malaria. The primary goal of this K24 will be to develop a cohort of young investigators with the skills required to conduct high quality translational research in the field of perinatal infectious diseases.